Extension of a longitudinal cognitive and brain imaging study of early-treated perinatally HIV infected children through adolescence

Project Summary
While the Eastern and Southern African region is home to 6.2% of the world's population, more than half
the world's HIV infected people live here. The biggest epidemic is in South Africa, with 7.2 million people living
with HIV. Although the rate of new infections has decreased dramatically worldwide from the peak in 1996, one
third (270,000) of new infections in Sub-Saharan Africa last year occurred in South Africa. Young adults are
disproportionately affected, with 37% of new infections in South Africa occurring in young women between the
ages of 15 and 24. Youth are similarly more likely to be infected in the United States.
Adolescence represents a critical period of brain maturation, with ongoing myelination, cortical growth and
synaptic pruning. Gradual and differential maturation of the limbic system and prefrontal cortex modulates
reward and affective behavior, and executive control. HIV infection and ART present further challenges to
neurodevelopment and resilience in this vulnerable stage of development. Cognitive impairment in HIV infected
children has been demonstrated in several domains, including memory, attention, and general intellectual
functioning. There is an urgent need for research on the longitudinal trajectory of neurodevelopment in
perinatally-acquired HIV infected (PHIV+) children and adolescents, especially in resource-limited countries.
In this study, we will extend our longitudinal follow-up of two extremely well-characterized PHIV+ cohorts,
adding neuroimaging and cognitive assessments at 14 and 16 years, and continuing 6-monthly clinical visits.
The study will include 80 PHIV+ children from the “Children with HIV early antiretroviral therapy” (CHER) trial,
originally supported by the Comprehensive International Program for Research on AIDS in South Africa
(CIPRA-SA). Controls were recruited by a CIPRA-SA supported interlinking vaccine trial. This cohort has been
followed clinically since birth, and with cognitive assessments and neuroimaging from the age of 5. The cohort
incorporates children who commenced ART before 12 weeks, and children whose treatment was delayed until
immunological criteria were met. We will also include 30 PHIV+ children from the IMPAACT (International
Maternal Pediatric Adolescent AIDS Clinical Trials Network) P1060 and P1104S studies who started ART at 2
to 36 months after exhibiting relatively advanced disease, and uninfected controls from the same cohort.
The Cape Universities Body Imaging Centre (CUBIC) houses a state-of-the-art research-dedicated
Siemens 3 T Skyra MRI scanner optimized for brain imaging, and unique in sub-Saharan Africa. We have
developed the capability for advanced brain morphometry, spectroscopy, diffusion tensor and functional
imaging. This project builds on a successful decade-long collaboration between Dr. Ernesta Meintjes
(University of Cape Town), Dr. Barbara Laughton (Stellenbosch University) and Dr. André van der Kouwe
(Massachusetts General Hospital). The project will build capacity including analysis methods for dynamic
functional imaging and advanced spectroscopic imaging techniques.

Public health relevance
Project Narrative Adolescence is an important period of cognitive, emotional and social change, with the brain undergoing substantial structural and functional development as it matures. Studies show that perinatally HIV infected (PHIV+) children display deficits in cognitive development relative to their uninfected peers. In this project we will continue to follow 110 PHIV+ children with cognitive testing, clinical assessments and neuroimaging through adolescence. These children were amongst the first globally to receive early antiretroviral therapy (ART). This project will complete the continuous study of these children from birth to the age of 16, after which the children are likely to leave school and disperse. This research will result in an improved understanding of the effects of HIV and ART on brain developmental trajectories from childhood to adolescence and this knowledge may guide public policy and treatment strategies.